Mechanisms of LRRK2 Mediated Neurotoxicity

DESCRIPTION (provided by applicant): Parkinson's disease (PD) is a major cause of morbidity and mortality in the United States. The etiology is largely unknown and therapies that slow or halt the relentless progression of disease do not yet exist. Dominant missense mutations in the leucine-rich repeat kinase 2 (LRRK2) gene are the most common known specific cause of PD, and LRRK2 mutations associate with disease phenotypes that mimic typical late-onset disease. LRRK2 encodes an unusually large protein kinase, and the most common mutations that cause PD may up-regulate LRRK2 kinase activity. Since small molecule protein kinase inhibitors have made an impact on the treatment of multiple types of cancer, LRRK2 represents a potential therapeutic target for the treatment of PD should kinase activity correlate with neurodegeneration in model systems. Through the design of novel high capacity viral vectors encoding the LRRK2 open-reading frame modified with either PD-causing mutations that up-regulate kinase activity or mutations that inactivate kinase activity, the importance of LRRK2 kinase activity in directing dopaminergic neurodegeneration in vivo will be determined. The specific effects of pathogenic mutations on LRRK2 function and activity are not fully understood, but may allow for a straightforward route to decipher disease-related LRRK2 functions. LRRK2 encodes an active kinase and GTPase protein, a near unique arrangement in the human proteome, and pathogenic mutations can occur in both enzymatic domains. Oligomerization and dimerization are intrinsic mechanisms of regulation for many protein kinases and GTPase proteins. We will biochemically characterize oligomeric and dimeric LRRK2 protein and determine the effect of pathogenic LRRK2 mutations on the composition of LRRK2 conformations and associated activities. Further, we develop technology that may allow direct visualization of LRRK2 enzyme activity in living cells and explore both inhibition and activation of kinase activity. Through the resolution of LRRK2 autophosphorylation sites, we have uncovered an unexpected complexity in the probable reciprocal regulation of kinase and GTPase activities, where kinase activity may play a dual role in mediating GTPase-dependent LRRK2 dimerization and kinase-mediated phosphorylation of substrates. We will characterize the role of LRRK2 autophosphorylation on enzymatic regulation and how PD-associated mutations perturb normal activities.

Public health relevance
PUBLIC HEALTH RELEVANCE: The biochemical mechanisms underlying disease-causing mutations in the LRRK2 gene, currently the most common known cause of Parkinson's disease, are explored in order to determine potential targets for therapeutics development. Identification of cellular pathways linked with LRRK2-mediated neurodegeneration will further enhance our understanding of Parkinson's disease and spur the development of rationally designed drugs that slow or halt the disease. Project Narrative The biochemical mechanisms underlying disease-causing mutations in the LRRK2 gene, currently the most common known cause of Parkinson's disease, are explored in order to determine potential targets for therapeutics development. Identification of cellular pathways linked with LRRK2-mediated neurodegeneration will further enhance our understanding of Parkinson's disease and spur the development of rationally designed drugs that slow or halt the disease. __SpecificAimsTextDelimiter__ A. Specific Aims Dominant missense mutations in the leucine-rich repeat kinase 2 gene (LRRK2) are the most common known cause of typical late-onset Parkinson's disease (PD), and are frequent in PD populations depending on ethnicity. In vitro studies suggest that PD-mutations increase kinase activity and LRRK2 toxicity may be kinase-dependent. In vivo models of LRRK2-directed neurodegeneration have not yet been described. Reproducible animal models of LRRK2-directed neurodegeneration and function in dopaminergic neurons are critically needed to help resolve LRRK2-related activities central to cell death and toxicity. The effects of pathogenic mutations on LRRK2 function and activity are not fully understood, but may allow for a straightforward route to decipher specific disease-related LRRK2 functions, which may highlight appropriate therapeutic targets. LRRK2 encodes an active kinase and GTPase protein, a unique arrangement (save LRRK1) in the human proteome and pathogenic mutations can occur in both enzymatic domains. Through detailed mass spectrometry analyses, we recently identified striking LRRK2 autophosphorylation in the ROC GTP-binding pocket. Kinase activity may play a dual role in mediating GTPase activity and GTPase-dependent LRRK2 dimerization and phosphorylation of substrates. Pathogenic mutations may perturb one or more aspects of this complex intrinsic signal transduction pathway. The development of in vivo models of LRRK2-directed dopaminergic cell death and the exploration of the mechanics of normal and disease-related enzymatic activation and regulation will hasten the exploitation of LRRK2 as a potential target for neuroprotection strategies in PD. Hypothesis 1: LRRK2 neurotoxicity is dependent on kinase activity in vivo Significance: The specific enzymatic or other LRRK2 activity responsible for neurodegeneration is not known, but this information is required for understanding pathogenic mechanisms in PD. To validate LRRK2 kinase activity as a plausible target for therapeutics by testing kinase-dependent toxicity in intact animals using well- described kinase-modified vectors, we will: 1A-Determine whether LRRK2-mediated toxicity in dopaminergic SNpc neurons is dependent on kinase activity through Ad-mediated transduction of kinase-overactive or kinase-dead LRRK2 in transgenic mice that express Ad receptor in neurons. 1B-Determine whether kinase-modified, disease-associated and wild-type LRRK2 over-expression in the mouse SNpc induces changes in the levels of dopamine and other monoamines in the striatum, a loss of fiber density in the striatum, and the accumulation of alpha-synuclein and ubiquitin in dopaminergic neurons. Hypothesis 2: LRRK2 dimerization is required for kinase activity. Significance: LRRK2 protein forms oligomers and dimer-sized structures that may determine enzyme activity and characterization of these structures may provide additional insight into the effects of pathogenic mutations and kinase regulation, and a means for determining kinase activity in living cells. We will: 2A-Assess the kinase activity of monomeric, dimeric and oligomeric WT and mutant LRRK2 protein. 2B-Visualize LRRK2 protein self-interaction in living cells through the use of protein complementation assays in combination with small molecule LRRK2 kinase inhibitors and compounds that enhance LRRK2 kinase activity. Hypothesis 3: LRRK2 autophosphorylation stabilizes protein dimerization Significance: LRRK2 forms kinase-dependent dimers and autophosphorylation sites cluster in the GTPase domain (described in preliminary data). Some or possibly all pathological-LRRK2 mutations increase rates of LRRK2 autophosphorylation, but the effects of autophosphorylation on LRRK2 function and activity are unknown. We will: 3A-Determine the sites of autophosphorylation in WT and mutant LRRK2 protein through the use of electron transfer dissociation (ETD) and collision-induced dissociation (CID) mass spectrometry. 3B-Determine the effects of phospho-mimetic aspartic acid or unphosphorylatable alanine residue substitutions in LRRK2 autophosphorylation sites on WT and mutant LRRK2 dimerization, kinase, and GTP-binding activity.